Ghrelin as Radiation Countermeasure: Mechanism of Its Action

PROJECT DESCRIPTION: This U01 project aims to elucidate a novel neuroenteric mechanism through which
ghrelin confers intestinal radioprotection, and to preclinically develop human ghrelin as a safe and effective
mitigator for gastrointestinal acute radiation syndrome (GI-ARS). Ghrelin is a small peptide secreted by the
stomach that readily crosses the blood-brain barrier. In our preliminary studies, ghrelin significantly improved
the intestinal integrity and survival in the context of inflammatory enteropathy. After radiation injury, serum
levels of ghrelin were markedly decreased, and ghrelin treatment significantly improved intestinal integrity,
increased crypt depth, and doubled the survival rate. Interestingly, ghrelin’s protective effects in radiation
combined injury were abrogated by prior subdiaphragmatic vagotomy, indicating that ghrelin primarily acts in
the central nervous system with its beneficial effects conveyed to the gut through the vagus nerve. Next, we
established ghrelin’s dose-response to improve survival after partial body irradiation, a better model to study
severe GI-ARS. After radiation exposure, dying intestinal stem cells (Lgr5+ cells) must be replenished by
otherwise quiescent clusterin (Clu+) revival stem cells. We demonstrated the feasibility of evaluating Lgr5+
stem cells as the target on ghrelin’s neuroenteric regulation, and showed that both Lgr5+ stem cells and Clu+
revival stem cells express cholinergic receptors. As such, we hypothesize that ghrelin mitigates radiation injury
via the efferent vagus nerve and the enteric nervous system to promote intestinal crypt Lgr5+ stem cell
recovery from Clu+ revival stem cells. Human ghrelin has been evaluated in Phase I clinical trials with an
excellent safety profile. Moreover, it can be synthesized in large quantities for mass emergency needs. Based
on our positive preliminary results, we also hypothesize that human ghrelin can be further developed as an
effective GI-ARS mitigator. In this proposal, we will elucidate ghrelin’s neuroenteric mechanism, its effects on
Lgr5+ stem cells and Clu+ revival stem cells, and its efficacy, PK, and safety pharmacology as a mitigator for
GI-ARS. These studies shall characterize human ghrelin’s novel mechanism of action and develop it as a safe
and effective countermeasure for victims of major radiation exposure.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT: Individuals exposed to high doses of ionizing radiation can develop deadly gastrointestinal acute radiation syndrome (GI-ARS) for which no specific treatment is yet available. In this project, we will elucidate a novel neuroenteric mechanism through which human ghrelin confers intestinal radioprotection, and leverage it to preclinically develop human ghrelin as a safe and effective radiation mitigator for GI-ARS. These studies shall provide novel insights into the control of intestinal healing by a new and effective treatment for victims of major radiation exposure.